Investigation of Dysfunctional Myelin Repair in Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is the most common form of dementia, and disease mechanisms important in
AD beyond amyloid and tau are not well defined. Myelin integrity is an understudied field in AD research and it
is currently not well understood why myelin injury that occurs in all aging adults is exacerbated to a pathologic
amount in those with AD. Decreased myelin quantity has been demonstrated in amyloid-positive preclinical AD
patients, which may be a separate process from gray matter degeneration seen in preclinical and prodromal
disease. Recent literature suggests that oligodendrocyte progenitor cells (OPC), which differentiate into
oligodendrocytes and promote myelin sheath maintenance and repair, are dysfunctional in AD. Microglia are
also known to contribute to myelin maintenance and repair specifically through the recently characterized glia-
to-glia signaling pathway downstream of microglia-derived transglutaminase-2 cross-linking enzyme (TG2),
which promotes OPC proliferation and thus myelination via g-coupled protein receptors. Although the literature
implicates impaired myelin repair in AD this pathway has not been investigated in relation to current AD
biomarkers. Of note, the acetylcholinesterase inhibitor donepezil promotes oligodendrocyte differentiation and
repair of the myelin sheath and provides significant therapeutic effect in animal models of demyelination. The
overarching objective of this proposal is to explore underlying mechanisms of myelin repair as drivers of
white matter degeneration, repair, and disease progression in AD. In Aim 1, I will analyze gene variants of five
candidate myelin repair genes, OLIG1, OLIG2, SOX10, SOX17, and MBP, which have been chosen due to
extensive literature support of their role in myelin repair and relative lack of assessment in AD to date. In Aim 2
I will analyze mRNA expression levels to understand functionality of these variants. Finally, in Aim 3 I will
investigate gene variants and mRNA expression of a candidate pathway that may be responsible for inhibited
myelin repair. This project will test two hypotheses: 1) genetic variations (SNPs) and mRNA expression of
selected myelin repair genes will be associated with both abnormal imaging and clinical biomarkers of AD; and,
2) genetic variations (SNPS) and abnormal mRNA expression of the upstream microglia-derived TG2-ADGRG1
signaling pathway, important in myelin repair, will be associated with abnormal imaging and clinical biomarkers
of AD. The project will use neuroimaging and genetic data in patients across the AD continuum, utilizing data
from the AD Neuroimaging Initiative (ADNI) and Indiana Memory and Aging Study (IMAS) cohort followed by the
NIA-designated Indiana ADRC. It will also allow me to shadow relevant clinicians as well as facilitate training in
imaging, genetics, and relevant neurobiology necessary to submission of a novel and translational doctoral
thesis.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is the most common form of dementia, and current therapeutics have targeted hallmark pathology of amyloid-beta plaques and neurofibrillary tau tangles to no avail. The proposed research will investigate the role of myelin sheath, the main component of the cerebral white matter, and how its ability to repair injury may be compromised in AD. This work will therefore describe how myelin integrity is controlled mechanistically through gene variants, mRNA expression, and will investigate a candidate pathway that may contribute to failed repair in AD to provide critical insight into mechanisms of neurodegeneration that can be targeted for therapeutics.